Cell-cell interactions in cerebellar development

Segal, Rosalind A. 2 R01 NS037757-10A2

Public health relevance
Relevancy to Public Health The proposed studies will investigate how growth factors induce directed migration of neural precursors. These investigations of polarity and migration will lead to approaches for restricting the extensive migration of malignant brain tumor cells that arise from neural precursors. In addition these studies will explain why errors in migration predispose to defects in brain circuitry in neuropsychiatric disorders such as dyslexia and autism.